QUICK PLACEMENT EEG ELECTRODE

DESCRIPTION: (Applicant's abstract) The electroencephalogram (EEG) electrode is a critical component for diagnosing and understanding neurological phenomenon. We have designed an innovative new electrode which will augment and further expand the EEG electrode's current use with emerging technologies. Electrode placement on the scalp is currently problematic, time consuming, and labor intensive. The new disposable electrode fulfills the requirements of standard silver/silver chloride, and provides signal quality equivalent to colloidal placed electrodes. However, this design uniquely provides the ability for quick placement without messy adhesives. The small size, high comfort level, and quick placement attribute make the device ideal for critical care, and ambulatory and extended monitoring. The goals, up through Phase III, are to design, prototype, validate, market, manufacture, and commercialize this novel electrode. PROPOSED COMMERCIAL APPLICATION: NOT AVAILABLE